Administrative Core

ABSTRACT: ADMINISTRATIVE CORE
The administrative core provides vital services for all members of the Program Project. In addition to
organization of, and planning for, the biannual all participants retreat, the annual scientific advisory board
meeting and the monthly teleconferences, the administrative core will arrange travel and hotel reservations for
all participants and SAB members. Additionally, the administrative core will track accounting for the three
projects and will generate all required institutional and NIH reports. The administrative core personnel are
highly qualified to accomplish these goals expeditiously and accurately with minimal distraction to
investigators, as they have proven in the past in the successful financial and logistical organization of many
national and international meetings at multiple venues (for the NHLBI Excellence in Hemoglobinopathies
Research Awards as the Academic Coordinating Center from 2012 to 2017, and for organizing the biennial
Hemoglobin Switching Conferences at the Asilomar Conference Center in California in 2008, 2012 and 2016).